Oral N-Acetylglucosamine as Anti-Neuroinflammatory Add-on therapy for Multiple Sclerosis (NANA-MS)

Abstract
In the demyelinating disease multiple sclerosis (MS), chronic-active brain inflammation, remyelination
failure and neurodegeneration remain major issues despite immunotherapy. While B cell depletion and
blockade/sequestration of T and B cells potently reduce episodic relapses, they act peripherally to allow
persistence of chronic-active brain inflammation and progressive neurological dysfunction. N-acetyglucosamine
(GlcNAc) is a triple modulator of inflammation, myelination and neurodegeneration. GlcNAc promotes
biosynthesis of Asn (N)-linked-glycans, which interact with galectins to co-regulate the
clustering/signaling/endocytosis of multiple glycoproteins simultaneously. In mice, GlcNAc crosses the blood
brain barrier to raise N-glycan branching, suppress inflammatory demyelination by T and B cells and trigger
stem/progenitor cell mediated myelin repair. MS clinical severity, demyelination lesion size and
neurodegeneration inversely associate with a marker of endogenous GlcNAc, while in healthy humans age-
associated increases in endogenous GlcNAc promote T cell senescence. A polymorphism linked to
dysregulation of GlcNAc metabolism most strongly associates with MS severity. In a recent mechanistic open-
label trial assessing oral GlcNAc at 6g (n=18) and 12g daily for four weeks in MS patients not in relapse and on
the immunomodulator glatiramer acetate, we reported that oral GlcNAc therapy was safe, raised serum levels,
modulated N-glycan branching in lymphocytes and lowered serum levels of pro-inflammatory IFNg, IL-17 and IL-
6. Oral GlcNAc also dose-dependently reduced serum levels of the anti-inflammatory cytokine IL-10, which is
elevated in the brain of MS patients. As glatiramer acetate acts peripherally, the reduction in inflammatory
cytokines and IL-10 by oral GlcNAc may arise from crossing the BBB to target chronic-active CNS inflammation.
Consistent with this, oral GlcNAc dose-dependently reduced serum neurofilament light chain (sNfL), a specific
marker of brain inflammation/neurodegeneration. Moreover, 30% of treated patients displayed confirmed
improvement in neurological disability; consistent with reduced brain inflammation and/or re-myelination. As
these observations were based on unblinded analysis, no placebo and small sample sizes, here we propose to
develop a multi-center double-blind randomized control trial to validate GlcNAc’s potential to improve residual
brain inflammation, myelin repair, neurodegeneration and neurological function. The study “Oral N-
Acetylglucosamine as Anti-Neuroinflammatory Add-on therapy for Multiple Sclerosis” (NANA-MS) will include
MS patients with ongoing chronic-active CNS inflammation (i.e. non-gadolinium enhancing paramagnetic rim
lesions (PRLs) on brain MRI) despite best available or no therapy. Primary outcome is the number of patients
with reductions in disability of at least 0.5 EDSS points. Secondary outcomes are change in 1) chronic CNS
inflammation based on brain MRI (i.e. decreased PRLs) and/or cerebrospinal fluid analysis, 2) peripheral
inflammatory markers, 3) myelination as assessed by Visual Evoked Potentials and 4) Quality of life measures.

Public health relevance
PROJECT NARRATIVE In multiple sclerosis, residual chronic active brain inflammation and failure of remyelination are major contributors to progressive neurological disability despite currently available treatments. Our previous studies in mice and humans implicated the simple sugar and dietary supplement N-acetylglucosamine in suppressing brain inflammation, promoting the re-growth of the myelin sheath, slowing brain degeneration and restoring neurological function. Here we propose to develop a clinical trial to assess the ability of oral Nacetylglucosamine to improve chronic brain inflammation, myelination, neurodegeneration and neurological function.